Pediatric Critical Care and Trauma Scientist Development Program (PCCTSDP)

Project Summary / Abstract
This is a proposal to continue the Pediatric Critical Care Trauma Scientist Development Program (PCCTSDP)
as a national program (not institutional) to support research career development for young faculty in pediatric
critical care and pediatric trauma surgery. The goal of the PCCTSDP is to increase the number of highly
trained, successfully funded and sustainable physician scientists in pediatric critical care and trauma surgery,
who will do translational research to enhance the scientific understanding of the pathophysiology and clinical
management of critical illness and trauma, with emphasis on long-term consequences of critical illness and
injury for children and families. In the first fourteen years of the program, 46 Scholars have been appointed, 28
have obtained their own K08 or K23 awards, and 6 have received at least one R01 award with many achieving
other federal and foundation awards. The PCCTSDP awardees (Scholars) are selected by a National Advisory
Committee (NAC) consisting of outstanding pediatric and trauma surgeon scientists who are leaders in the
field. Two new Scholars are appointed annually. Applicants will identify an outstanding scientific mentor,
potentially at an institution separate from their fellowship training, and will be sponsored by their department
chair. Each Scholar will spend 2 years in an intense research training environment in basic, clinical or
translational research, with a minimum of 75% protection from non-research responsibilities (Phase I). In the
subsequent 3 years (for a total of 5 years), Scholars must be financially supported by their institutions to
continue to have at least 50% - 75% protection to transition into independent investigators (Phase II). Scholars
are expected to apply for their own extramural funding in the form of a K or R level award in the first 18 months
of the K12 award. PCCTSDP conducts an annual scientific retreat during which Scholars will interact with the
NAC members and NIH staff, present their scientific work, discuss their career development plans and
progress, and participate in selected workshops on faculty development, grant writing, mock grant reviews, and
other relevant topics. By providing extended training and protected time to develop outstanding skills in these
young faculty, the PCCTSDP will continue to increase the pool of skilled investigators in pediatric critical care
and trauma.

Public health relevance
Project Narrative Pediatric critical care and trauma physician-scientists discover knowledge that is vital for the health of children. The nation is facing a shortage of pediatric critical care and trauma physician-scientists. The goal of the PCCTSDP is to increase the number of diverse, well-trained, successfully funded physician-scientists in pediatric critical care and trauma surgery who are capable of sustaining careers in basic, clinical, translational and health services research that advance the understanding and care of critically ill and injured children and their families.